Investigating non-canonical mechanisms of endogenous opioids on motivation in dorsal midbrain

Project Summary
The primary goal of this R01 is to determine the computational and functional role of endogenous opioids in
specific dorsal midbrain nuclei on motivated behaviors. The preponderance of mental illness in the United States
results in tens of millions of dollars in healthcare costs. While many neuropsychiatric conditions can be
dissociated based on the presence or absence of specific features, a common theme across mental illnesses is
the dysregulation of affective or motivated behaviors. The endogenous opioid system is known to powerfully
modulate affective and motivational neural circuits. Historically, dorsal midbrain nuclei (including ventrolateral
periaqueductal gray nucleus and the adjacent dorsal raphe nucleus) have been shown to be important sites for
opioid action. More recently, the lateral dorsal raphe nucleus subregion (LDRN) and nucleus accumbens were
shown to be important sites in an opioid-mediated mesolimbic circuit of appetitive motivation. However, while
downstream opioid activity in this LDRNaccumbens circuit specifically enhances appetitive motivation,
convergent studies indicate that endogenous opioids may play a motivationally suppressive role within LDRN
itself. For example, experiments in the 1980s demonstrated morphine microinjections into ventrolateral
PAG/LDRN could suppress food intake. Correspondingly, pilot studies in our lab using a CRISPR-Cas9 mediated
knockdown of opioid peptides oppositely facilitated food intake. Furthermore, local LDRN opioid activity appears
to suppress both appetitive and aversive motivated behaviors (e.g., local opioid antagonism in LDRN increases
defensive or escape behaviors). These broad, anti-motivational opioid effects suggest that dysregulation could
affect a wide range of affective or motivated behaviors. Therefore, the goal of this R01 application is to determine
how endogenous opioids regulate appetitive and aversive motivated behaviors in LDRN by multiplexing genetic,
pharmacological, in vivo imaging, and optogenetic technologies. First, we will identify the anatomical
characteristics of opioids within dorsal midbrain nuclei (Aim 1). In tandem we will test the functional localization
of opioids by performing receptor selective pharmacological antagonism via wireless fluidic devices and
CRISPR-Cas9 knockdown of opioid peptides. Next, we will use dual-color 1-photon endoscopic imaging to
examine how local opioidergic and non-opioidergic neurons interact to encode appetitive and aversive behaviors
(Aim 2). Follow up experiments will use simultaneous 1-photon imaging with cell-type selective optogenetic
neuromodulation to augment or disrupt LDRN encoding and expression of motivated behaviors. Finally, we will
multiplex 1-photon imaging, CRISPR-Cas9 knockdown, and cell-type specific optogenetic stimulation to
determine how endogenous opioid peptides casually augment LDRN encoding and expression of motivated
behaviors (Aim 3). Together, these studies may provide insights into how neuropsychiatric disorders are often
characterized by affective and motivational dysregulation, and suggest specific neurochemical targets for
therapeutic intervention.

Public health relevance
Project Narrative Over the course of a lifetime, 20% of adults in the United States will experience mental illness. Many neuropsychiatric disorders are characterized by dysregulation of affective or motivated circuits in the brain, both of which are highly sensitive to endogenous opioid signaling. Here, we seek to leverage next-generation, opioid specific technologies to determine the biological and computational function of endogenous opioids in regulating motivated behaviors.